Efficacy Study of A Nicotine Barrier Cream

DESCRIPTION (provided by applicant): Tobacco is a very important part of the culture and agricultural economy in Kentucky, and is grown in 119 of its 120 counties. It is also grown in other states and around world. Tobacco harvesting workers are exposed to nicotine from wet tobacco plants. Approximately 1-47% of exposed workers may develop green tobacco sickness (GTS) that can be so severe, requiring emergency medical treatment. GTS causes significant discomfort and lost productivity. Current preventive measures using protective clothing or work schedule change may not be feasible and practical due to field limitations. New strategies for exposure control are needed. Barrier creams are often used in the workplace as an effective tool together with other protective methods to reduce exposure to chemicals. However, no nicotine barrier cream products are currently available. We propose to develop such a barrier cream and test it in vitro and in Kentucky tobacco farm workers. Nicotine in tobacco exists as a lipophilic free base and readily penetrates the skin. Nicotine forms a water-soluble salt with organic acids which we hypothesize may significantly lower its permeation through the skin and absorption into the blood. Our specific aims are: 1) to develop a nicotine barrier cream and identify optimal formulations in the laboratory; 2) to assess its efficacy in reducing dermal absorption of nicotine using in vitro testing; 3) evaluate its efficacy, acceptance, side effects ad feasibility in a field pilot study. Our approaches include: 1) develop barrier cream formulations and cleaning towelettes; 2) conduct in vitro testing to identify optimal formulations; 3) recruit 2 tobacco farms and 40 farm workers and randomly assign them to one of the two groups who will randomly receive one of the formulations; 4) collect urine samples and analyze them for nicotine and cotinine content; 5) test differences in nicotine exposure with and without the use of a barrier cream and between formulations; 6) assess barrier creams' acceptance/feasibility with workers. This pilot study may allow us to obtain preliminary data that would aid in future experimental intervention study design to evaluate the relative contributions and effectiveness of different types of strategies and protective technologies in reducing skin exposure to nicotine in tobacco farming, in addition to assessing the potential risk reduction of GTS. Our long-term goal is to use the research results to change the work practice and help prevent GTS in tobacco farmers and farm workers particularly migrant and seasonal farm workers and improve their health and safety. It is in accordance with the NIOSH new NORA agenda in this industry sector.

Public health relevance
PUBLIC HEALTH RELEVANCE: This study addresses one of the significant health hazards in the tobacco farming industry, nicotine exposure of tobacco farmers and farmer workers particularly migrant and seasonal farm workers. Tobacco farming is included in the NORA sector "Agriculture, Forestry & Fishing". The study also addresses one of the NIOSH's cross-sector program areas - personal protective technologies. It has the high probability of translating research results into public health practices. Currently, no nicotine barrier cream products are available in the market so far as we know. The developed barrier cream if effective in both the laboratory testing and field evaluation with workers will help future intervention studies to evaluate its relative efficacy in comparison with other nicotine exposure control measures, which has the potential to advance the protection technology in this field and change the exposure control practice in this industry. It may also help reduce the risk of developing green tobacco sickness. It is well in accordance with NIOSH missions and research agenda in this industrial sector. __SpecificAimsTextDelimiter__ Efficacy Study of A Nicotine Barrier Cream 2. SPECIFIC AIMS Tobacco is a very important part of the culture and agricultural economy in Kentucky where it is grown in 119 of its 120 counties. There are approximately 60,000 tobacco farms where 60,000 workers harvest tobacco annually on at least a part-time basis. Tobacco is also grown in Texas, other parts of the U.S., and around the world. Tobacco farmers and farm workers may have significant skin exposure to and subsequent absorption of dissolved nicotine from wet tobacco leaves or saps during the harvesting process, which can result in green tobacco sickness (GTS) with a series of symptoms that may be sufficiently severe to require emergency medical treatment. There have been published case reports of GTS in Kentucky,Florida, Tennessee and North Carolina, as well as other parts of the world. The estimated incidence rate varies from 1% to 47%. Despite the seriousness of GTS and the large number of workers exposed, there has been very little regulatory effort to address prevention and effective strategies to reduce exposures to nicotine from tobacco harvesting in workers, especially in migrant and seasonal farm workers. The current measures using protective equipment such as chemical-resistant gloves and waterproof rain gear in addition to work schedule change may not be feasible and practical due to various limitations: including a hot work environment, busy work schedule and the rapid absorption of nicotine into the skin and subsequently into the blood stream. Alternative protective strategies are needed and should be actively sought. Nicotine exists in tobacco as a lipophilic free base that readily penetrates the skin. Nicotine forms a water-soluble salt in combination with organic acid such as ascorbic acid, tartaric acid or citric acid. Application of a barrier cream containing such organic acid could largely eliminate the adverse outcome of nicotine exposure, by converting the free base to a salt and possibly reduce the transdermal absorption of nicotine and the risk of GTS. We seek to develop this novel nicotine barrier cream and evaluate its efficacy in vitro and in the tobacco harvesting environment. We hypothesize that an organic acid-based barrier cream can be developed and would reduce the nicotine flux and effectively protect tobacco farm workers from exposure and subsequent absorption of nicotine in a workplace testing, which may further help reduce the risk of GTS in tobacco farm workers. Our primary goal is: To develop a novel nicotine barrier cream, conduct in vitro testing to evaluate its efficacy and a pilot field study to evaluate the reduction in nicotine exposure from tobacco harvesting in Kentucky farm workers. Our long-term goal is to conduct intervention studies that would assess the relative effectiveness of barrier creams vs. other protective technologies, and exposure reduction strategies, and evaluate the possible reduction in risk of developing GTS in the tobacco farming industry. Specific aims to support the goal: Aim 1: To develop a nicotine barrier cream and identify optimal formulations in the laboratory. Aim 2: To assess its efficacy in reducing dermal absorption of nicotine using in vitro testing. Aim 3: To evaluate its efficacy, acceptance, side effects and feasibility in a field pilot study. The overall study design will be a one-year in vitro testing study and one-year field pilot study with prospective recruitment and evaluation of 1 to 2 large tobacco farms and 40 tobacco farmers and farm workers. The participants will be assessed for nicotine exposure in two phases: Phase I - Baseline - no nicotine barrier cream formulations will be used during harvesting; and Phase II - Evaluation - when the nicotine barrier cream formulations are used. The approaches: 1) develop and identify barrier cream formulations and cleaning towelettes; 2) conduct in vitro testing to assess optimal formulations; 3) recruit tobacco farm workers and randomly assign them to one of the two groups who will randomly receive one of the formulations; 4) collect urine samples and analyze them for nicotine and cotinine content; 5) assess barrier creams' acceptance/feasibility subjectively; and 6) test differences in nicotine exposure with and without the use of barrier creams and between formulations. Impact and potential for public health translational research: This RO3 Grant application has the following potential impact: 1) innovate effective, acceptable, feasible and no harm nicotine barrier cream formulations; 2) identify potential factors affecting the efficacy, acceptance, feasibility and side effects of the barrier cream; 3) reduce nicotine exposure and skin absorption in tobacco farm workers, and 4) possibly reduce adverse health impacts and implications from nicotine exposure in these workers. This pilot study may allow us to obtain preliminary data that would aid in future experimental intervention study design to evaluate the relative contributions and effectiveness of different types of strategies and protective technologies in reducing skin exposure to nicotine in tobacco farming, in addition to assessing the potential risk reduction of GTS. Eventually we aim to educate and train tobacco farmers, farm workers, particularly migrant and seasonal farm workers to use protective technologies and strategies to potentially reduce their nicotine and possibly other agricultural chemical exposure and improve farm worker health, safety and work practice.